ORISE Research Participation Program

The purpose of this agreement is to provide funding to DOE in support of the ORSE Research Participant Program at NCI. This program will provide opportunities for faculty, students, recent graduates, and other research scholars and scientists to participate in on-going research programs, projects, and activities that support the NCI.